Integration And Remodeling Of Bioprinted Skin In Full-Thickness Wound Healing

PROJECT SUMMARY
This project will provide multidisciplinary training for a dual-degree MD/PhD student in skin tissue engineering
and burn reconstructive surgery, addressing an unmet clinical need for a skin substitute with full-regeneration
potential. Burn injuries are a major clinical burden in the United States, with nearly 500,000 patients treated
annually, a mortality rate of 4.9%, and an estimated cost of $2 billion per year. The standard of care for burn
injuries includes autologous skin grafting, but these procedures require sufficient harvest sites that are scarce
in patients with severe wounds. Tissue-engineered skin substitutes offer a promising alternative to skin grafts.
However, current prototypes contain only up to two cell types; lack sweat and sebaceous glands, hair follicles,
and pigmentation; and may not stimulate revascularization and innervation. Since the ultimate goal of a skin
graft is to regenerate authentic anatomy and physiology of native skin, there is an immense need to develop
bioengineered skin with more cell types and full regeneration potential. To meet the need for bioengineered
skin, bioprinting techniques have been developed to more accurately engineer tissue substitutes with
appropriate 3D structural organization. This proposal will test the hypothesis that a 3D bioprinted skin graft will
support regeneration of native-like skin in full-thickness wounds in vivo, similar to skin autografts. To test this
hypothesis, the fellowship applicant has proposed three Specific Aims. Aim 1 will delineate how bioprinted skin
accelerates epidermal barrier formation in vivo. This aim will provide the applicant with training in digital
planimetry analysis to measure rates of wound closure, and NOVATM dermal phase meter analysis to measure
the extent of re-epithelialization over time. Aim 2 will explore how neovascularization occurs in bioprinted skin
in vivo and will require competence qrtPCR to measure endothelial growth factors compared with IHC stained
capillaries per mm2. Aim 3 will investigate how melanocyte migration impacts bioprinted skin pigmentation.
This will require immunohistochemical staining to determine mouse vs. human tissue formation, hair follicle
formation, and melanin production. The applicant has assembled a multidisciplinary team of sponsors, co-
sponsors, contributors, and consultants with expertise in regenerative medicine, ECM imaging, biomaterials
science, wound healing, dermatology, and burn reconstructive surgery. They have established a training plan
with (1) Mentorship Meetings, (2) Coursework, (3) Research Training, and (4) Clinical Training that will allow
the student to develop both technically and conceptually towards becoming an independent skin tissue
engineer. This novel approach to treatment of full-thickness wounds, conducted at a world-class institute, will
serve as a basis for the student's training, and allow this promising applicant to develop as a physician-
scientist poised to address future deficits in burn reconstructive surgery through skin tissue engineering.

Public health relevance
PROJECT NARRATIVE Given the clinical burden of burn wounds among military and civilian populations, the limitations of currently available skin substitutes, and the ultimate goal to regenerate authentic anatomy and physiology of native skin, there is an immense need to develop skin graft alternatives. Bioprinted skin with a full repertoire of cells and regeneration potential could ultimately provide permanent wound closure for burn patients, with restoration of the skin barrier, replacement of the epidermis, dermis, and hypodermis, and achievement of functional and cosmetic results similar to autografts and native human skin. This innovative approach to treatment of full- thickness burns could help relieve the clinical burden of burn injuries, result in decreased scaring and morbidity with improved quality of life for patients who suffer from these ailments, and serves as the basis for technical and conceptual training of the fellowship applicant in skin tissue engineering and burn reconstructive surgery.